Specialized Mitochondrial DNA Polymerases in African Trypanosomes

Trypanosomatid parasites infect diverse species of insects, animals, and plants, but are best known as causative
agents of the Neglected Tropical Diseases human African trypanosomiasis, Chagas disease and Leishmaniasis,
some of which are fatal without intervention. New, selective, short-course trypanocidals are needed for human
and animal infections. Trypanosomes have one of the most complex mitochondrial genomes in nature called
kinetoplast DNA (kDNA) that is a catenated network composed of maxicircles and minicircles. The kDNA
structure and replication mechanism are divergent from all other eukaryotes, and is essential for parasite
survival and life cycle completion. Prominent features of the kDNA replication model include release and
attachment of minicircles, and remarkably, persistent nicks and gaps in the newly replicated molecules that are
not repaired until the segregation of daughter networks. This suggests that the DNA damage tolerance
response during kDNA replication is essential and therefore notably different in trypanosomatids. Lastly, while
most eukaryotes rely on one essential mitochondrial DNA polymerase (Pol), T. brucei uses three family A DNA
Pol paralogs (POLIB, POLIC, POLID) that are independently essential to maintain the kDNA network
suggesting these proteins have evolved specialized functions. Our long-term goal of determining how multiple
DNA Pols are used to maintain the kDNA network is key to gaining a deeper understanding of how to selectively
interfere with this essential process.
This project will clarify the roles of POLIB and POLID in kDNA replication and evaluate essential functional
domains responsible for responding to replication stress. We address the functions of POLIB and POLID using
a system with multiple inducers that allow independent, tunable, and temporal regulation of gene expression
for detailed mechanistic studies. Aim 1 will define roles of POLIB and POLID in kDNA replication through RNAi
complementation with a focus on maxicircle replication and proofreading replicative roles. Aim 2 will establish a
novel triple control induction system to induce kDNA-specific replication stress and subsequently evaluate the
roles of POLIB and POLID under replication stress conditions through RNAi complementation. Our findings will
clarify the specialized roles of POLIB and POLID paving the way to elucidate the division of labor among the
Pol paralogs, a feature that has been enigmatic in the long-held kDNA replication model. The Pol paralogs are
preserved across kinetoplastids, therefore a mechanistic understanding of POLIB and POLID in T. brucei has
the potential for a broad-based anti-trypanocidal, and to provide a rare opportunity to study features that have
evolved for Family A DNA Pols.

Public health relevance
PROJECT NARRATIVE Trypanosomatids are unicellular parasites that cause devastating diseases in humans and animals. This project will determine the in vivo roles of POLIB and POLID, two key components required for mitochondrial DNA maintenance in both human and insect stage Trypanosoma brucei. The proposed studies will significantly increase our mechanistic understanding of mitochondrial DNA replication in a medically and economically important parasite and has the potential to guide discovery of a broad- based anti-trypanocidal.